Direct targeting of HIF1a-driven transcription in TNBC with engineered STRs

Project Summary: Tumor cells are exposed to a wide array of stressors ranging from hyperactive protein
synthesis and metabolism to nutrient and oxygen starvation in the tumor microenvironment; these stimuli require
tumor cells to activate protective transcriptional programs that promote tumor cell survival and growth. X-box
binding protein 1 (XBP1) and hypoxia-inducible factor 1 alpha (HIF1a) are two of the most important stress-
induced transcription factors (TFs), activate oncogenic and metastatic gene expression programs by assembling
into complexes at unfolded protein response (UPRE) and hypoxia-induced response (HRE) elements,
respectively. These target DNA sequence ‘motifs’ overlap in many target genes. Triple negative breast cancer
(TNBC), the most aggressive and metastatic subtype of breast cancer, is heavily dependent on strong
upregulation of XBP1s (the spliced, active form of XBP1), HIF1a and their downstream stress-responsive gene
expression networks. Despite the profound need for targeted therapies against these and other oncogenic TFs,
they remain largely untapped as drug targets due to the challenges of targeting protein-protein and protein-DNA
interactions. Therefore, our team recently developed a modular strategy to create fully synthetic transcriptional
repressors (STRs) to directly inhibit the oncogenic activity of TFs by blocking their ability to bind and regulate
specific DNA sequences. Using this synthetic platform, we have designed potent (low nM), highly specific, cell
permeable, and in vivo active inhibitors of HRE/UPRE-driven transcription. Our lead STRs directly antagonize
XBP1/HIF1a for DNA binding in vitro and in cells, resulting in potent, global inhibition of hypoxia-induced gene
expression programs, blockade of hypoxia-induced aggressive phenotypes, such as cell invasion, and anti-
proliferative effects only under conditions of hypoxia. In animal studies, administration of lead STRs significantly
inhibits tumor growth and hypoxia-induced gene expression, validating on-target activity in animals. The
proposed project will test the hypothesis that XBP1/HIF1a transcriptional responses can be tightly controlled by
optimized STRs that directly target their shared DNA binding sites. This will be accomplished through three
complementary Aims: 1) Develop ultra-potent, pharmacologically stable STRs for cell based and animal
studies; 2) Map STR-based reprogramming of hypoxia-induced, XBP1/HIF-dependent gene expression and
oncogenic phenotypes in TNBC; 3) Test efficacy of optimized STRs in inhibiting TNBC growth, metastasis and
chemoresistance using in vitro and in vivo models. These studies will provide fresh insight into the molecular
underpinnings and pathogenesis of adaptive stress responses in TNBC, determine the effects of blocking
XBP1/HIF1a -DNA binding at the level of chromatin and transcriptional dynamics and establish the efficacy of
targeting hypoxia-dependent gene expression on TNBC tumor growth, metastasis and chemotherapeutic
sensitivity.

Public health relevance
Project Narrative Transcription factors (TFs) have been implicated in many diseases like cancer, but despite their high therapeutic potential the vast majority of TFs have resisted traditional drug discovery efforts. To address this challenge, we developed a new and generally approach to create synthetic transcriptional repressors (STRs), which can potently and specifically bind to target DNA sequences to thereby block cancer-causing TFs from regulating gene expression. We now propose to design and test more potent and specific STRs that directly block XBP1/HIF1alpha-DNA binding, profile their effects on oncogenic gene expression programs, and evaluate their therapeutic efficacy in cell and animal models of triple negative breast cancer.